Measuring and Improving the Safety of Test Result Follow-Up

Background: Electronic health records (EHRs) can improve communication processes but unique vulnerabilities
remain. Failure to follow-up abnormal test results (“missed results”) is a key preventable factor in diagnostic
delays in the VHA and often involves EHR-based communication breakdowns. Our work, as well as data from
root cause analyses and malpractice claims in the VA, highlights many technical and “social” (i.e., workflow,
organizational, people, and policy) variables that affect test results communication and follow-up.
Objectives: We will develop and evaluate a new program for surveillance and improvement of test results-
related diagnostic safety. This will include development, implementation, and evaluation of a change package
(i.e., a catalogue of strategies, change concepts, and action steps that guide participants in their improvement
efforts15) that identifies and addresses risks that predispose health systems to missed test results.
Unique features & Innovation: In a 2017 National Quality Forum report “Improving Diagnostic Quality and
Safety”, several measurement concepts related to test results follow-up were proposed for further development.
We developed and tested a novel electronic indicator system of triggers for missed test results, which uses
automated methods to find patients meeting specific criteria using Corporate Data Warehouse (CDW) data.
Triggers are signals that can identify patients at higher risk of harm and alert providers to review records for
potential patient safety events. Our team has used triggers to identify specific data patterns to facilitate selective
chart reviews. We have achieved reasonable positive predictive values (PPVs) and negative predictive values
(NPVs), and aim to have these tools used at the system level to measure care delays more efficiently. This
measurement system has the potential to become a near real-time surveillance system to identify patients whose
test results might have been missed. However, identifying safety deficits using triggers within the CDW is only
the first step. For these reports to result in improvements, a team (clinical or organization-based) must analyze
the data and create a feedback system to generate learning and improvements. Our change package aims to
help VA facility-based teams implement a surveillance and improvement program, ensure that safety
measurement will translate into action and help them create back-up systems to monitor diagnostic delays.
Methods: Working with 2 operational partners (NCPS and VA Primary Care), our specific aims are:
Aim 1: Develop and pilot test a “change package” (SAFER Change Package) to provide VA facilities guidance
on how to implement a surveillance and feedback program related to missed test results.
Aim 2: Evaluate if the “SAFER TRACKS” Intervention (SAFER Change Package delivered using a Virtual
Breakthrough Series [VBTS] Collaborative supplemented with automated surveillance data on test results) can
reduce missed results using a stepped-wedge cluster-randomized control trial. Our outcome measures will be
the rate of missed test results, determined through random manual medical record review conducted nationally
as part of the VHA performance-measurement system, as well as automated `trigger' indicators of missed test
results. We hypothesize there will be fewer missed test results in participating sites during the SAFER TRACKS
Intervention as compared to during the pre-intervention period.
Aim 3: Evaluate the implementation of the SAFER TRACKS Intervention through mixed-methods in order to
determine strengths and challenges at participating sites.
Our outputs will include multifaceted socio-technical tools and strategies to help prevent, detect, mitigate, and
ameliorate breakdowns in EHR-based communication that often lead to missed test results in the VHA.
Significance: The project is responsive to “Targeted Solicitation for Health Services Research on Data and
Measurement Sciences – A Learning Health Care System Initiative” and to HSR&D's Major Priority Domain of
Healthcare Informatics and Sub-domain for innovative uses of information technology to improve diagnosis.

Public health relevance
In the last few years, “missed” diagnostic test results, i.e., those with absent or delayed follow-up, have been determined to be a significant patient safety problem in the VA. While thousands of veterans have abnormal test results every day, there are currently no methods to identify opportunities to reduce care delays. Rigorous measurement and improvement of diagnostic safety can thus benefit veterans and should be prioritized given the increasing amount of electronically available data. We will develop a multi-faceted measurement and improvement approach and build on recommendations from the recent IOM report “Improving Diagnosis in Health Care” to improve veterans' outcomes related to follow-up of abnormal test results. We will develop and evaluate a new VA facility-based systems approach for surveillance and improvement of test results follow-up. Our project is relevant to several VA national policy initiatives related to measurement and safety improvement and builds on our extensive work in improving patient safety related to the diagnostic process.